Administrative Core

The Administrative Core plays an essential function in facilitating the scientific interactions between all projects and the other Cores and in providing support on issues related to overall finances and personnel management. The responsibilities of this core are: 1) management of all budgetary matters and record keeping of this Program Project Grant, including documentation related to personnel salaries, fringe benefits, health care and insurance, purchasing of supplies and expediting orders and services; 2) serving as an interface between the investigators and the Medical Center Administration for material transfer agreements and update of protocols for biosafety, isotopes, recombinant DNA an IACUC; 3) Integrating and facilitating scientific exchange between the five projects. Dr. Cardoso and Dr. Fine will serve as the PI and Co-Pi of this core, respectively. They will schedule and chair weekly meetings with the project leaders and their groups for discussion of scientific data, research directions, and further identification of synergies between projects; 4) organization of the progress reports and non-competitive renewals of this grant. 5) Organization of the visits and discussion of all meetings with the Internal and External Advisory Board. This includes the scheduling and travel arrangements of the external advisors and writing of the scientific reports. This Core has been highly helpful and efficient in performing all the above functions